HIV-1 mediated membrane fusion as a target for therapy

Summary: (1) Goals of project: - To develop biological and biochemical assays for monitoring HIV-1 envelope-mediated cell fusion and formation of the tri-molecular complex between gp120/CD4/co-receptor. - To study the expression and function of HIV-1 co-receptors on primary human cells known to be targets for HIV-1 infection, and to study the effects of pro-inflammatory cytokines on the function of the HIV-1 co-receptors and infectivity of primary human cells. - Development of agents capable of blocking infection by cell-free or cell-associated HIV-1. (2) Experimental approach: - Biological (Ca++ flux, chemotaxis, HIV-fusion) and biochemical assays were developed to measure the association of the CD4/gp120 complex on human cells with the HIV-1 co-receptors for T-tropic and M-tropic envelopes (CXCR4 and CCR5). They included co-immunoprecipitations of CD4/co-receptors from cell lines and from primary human cells (i.e., monocytes and macrophages), and Western blots of whole cell and membrane extracts using our rabbit anti-CXCR4 and anti-CCR5 reagents. - Studies were conducted on multiple cell types: Langerhans cells (LC), dendritic cells (DC), Thymocyte subsets, CD34+ progenitors, peripheral blood T cells, monocytes (MO) and macrophages (MDM). - Develop new reagents for immunoprecipitation and Western blot analyses of the key HIV-1 co-receptors (CXCR4, CCR5). - Apply new biochemical assays including "Proteomics" to identifying the post-translational modifications of HIV-1 co-receptors that affect their function in primary human cells. (3) Major Findings: - In biochemical studies on monocyts and macrophages (MO/MDM) it was found that the post translational modification of CXCR4 is significantly different in MO vs. MDM. In Mo all the CXCR4 molecules appeared monomeric, while predominantly high MW species of CXCR4 were found on the surface of MDM. The transition from low to high CXCR4 MW species correlated with loss of fusion with T-tropic (X4-) envelopes. -Coreceptor competition for association with CD4 may change the susceptibility of human cells to infection with T-tropic and M-tropic isolates. - Multiple species of CXCR4 were detected in total cell extracts from human lymphocytes, monocytes, and macrophages. Only some of these specied can be precipitated by monocolonal antibodies against CXCR4. - We used 1-D and 2-D gels to resolve CXCR4 from differnt cells types and subject them to proteomic analyses (pending) - We found strong evidence that the high MW species of CXCR4 in lymphocytes and macrophages represent ubiquitinated molecules. At least a portion of these molecules are found on the surface of cells and may participate (or interfere)in the fusion process with HIV-1. - Derivatives of a cyclic CXCR4 inhibitor (T22) with Tags at the N- or C-terminal were synthesized by the CBER Core facility. These cyclic peptides were shown to bind well to cells expressing CXCR4 and to induce CXCR4 downmodulation and HIV-1 env-mediated cell fusion. These tagged -peptides will be tested in immunoprecipitation of CXCR4 from various human cells